Colliculopulvinar contributions to alpha dysregulation and cognitive dysfunction in schizophrenia

Schizophrenia (Sz) is a severe psychiatric disorder associated with core neurocognitive
deficits. Although, traditional models of schizophrenia focus on dysfunction within cognitive and
sensory processing cortical regions, increasing evidence has accumulated suggestive of
subcortical processing impairments as well. Deficits along the subcortical visual pathways,
especially involving the magnocellular visual pathway, have been tied to deficits in the
generation of early cortical responses which, in turn, contribute to higher-order cortical
impairments. These deficits, however, may not account for all visual information processing
abnormalities in Sz. Recently, we have observed deficits in the modulation of ongoing scalp-
recorded alpha activity, which appear independent of the traditional magno/parvocellular
pathways, and which may be mediated by dysfunction of the “retinotectal” visual pathway, which
involves the superior colliculus (SC) and the pulvinar nucleus of the thalamus (PuN), but which
bypasses the lateral geniculate nucleus (LGN). At present, tools for the evaluation of the
retinotectal system within neuropsychiatric populations remain limited. In this project we will
conduct a side-by-side comparison of potential paradigms gleaned from the basic science
literature to elicit PuN/SC activation and will study their feasibility and psychometric properties.
These paradigms will then be used to assess the integrity of PuN/SC processing in Sz relative
to alpha generation and cognitive performance.

Public health relevance
PROJECT NARRATIVE Sensory deficits in the visual system are characteristic of several psychiatric disorders including schizophrenia, autism and attention deficit/hyperactivity disorder. In the case of schizophrenia, these deficits are seen even in the unaffected first-degree relatives of patients, suggesting a genetic component. Thus, the study of the neural correlates of visual processing impairments may reveal factors that make the brain vulnerable to psychosis and to the etiology of schizophrenia and other mental disorders that directly impact public health.